ACHIEVE Administrative Core

Abstract
The Administrative Core brings together a multidisciplinary team of investigators and research support staff to
focus on a strategy to build synergy and efficiency within and across three major research universities to focus
on the amelioration of cardiometabolic disease disparities. The Administrative Core will provide key oversight
to ensure that the proposed ACHIEVE GREATER Center is a fully integrated, well-oiled machine whose
investigators are successful in training the next generation of disparities researchers, while conducting
research that accomplishes the overall goal of improving downstream lifespan equality by controlling major
cardiometabolic risk factors that contribute disproportionately to midlife mortality in minority populations. In
order to coordinate these efforts, the Administrative Core manages operations, monitors progress toward
Center goals and implements quality improvement strategies to resolve barriers, and facilitates communication
to ensure timely progress toward Center goals, access to Core services and adherence to NIH regulations.
The following specific aims for the Administrative Core reflect these goals:
Aim 1. Provide fiscal and operations management for ACHIEVE GREATER, including all coordination and
oversight for administration of the program within the Coordinating Center and amongst project leaders, Core
directors, partner institutions, regional collaborators, and stakeholders.
Aim 2. Support the development, implementation and coordination of the ACHIEVE GREATER scientific
agenda and streamline access to resources, including Administrative Core research services
Aim 3. Monitor progress and evaluate effectiveness of ACHIEVE GREATER, maintaining open communication
with Core and project leadership as well as stakeholder advisors, with early intervention to improve the
likelihood that the Center accomplishes its goals, when necessary.
Aim 4. Achieve sustainability, cultivating additional institutional, regional and national support for a permanent
center.